Predoctoral Training in Quantitative Cell & Molecular Biology

Project Summary
Graduate students face a stressful transition to the job market, a national mental health crisis, and ongoing
racial and gender bias – all issues that can be improved with faculty mentoring that follows best-
practices. High quality mentoring experiences for graduate students result in an enhanced science identity,
greater persistence in the field, higher research productivity and greater career satisfaction for graduate
students in STEMM. High quality mentoring increases sense of belonging and self-efficacy, which have the
potential to positively impact graduate student's mental health. High quality mentoring also enhances
recruitment of underrepresented groups and can improve the graduate experience for minoritized students and
those with intersectional identities by providing psychosocial support and increasing inclusion. Aim of this
proposal is to ensure that faculty within Colorado State University (CSU) are providing the best quality
mentoring to our graduate student participants of the NIH funded qCMB program, and other programs all
through the university, and to also prepare our graduate students for mentoring roles as they progress through,
and after they graduate, from this program. To do so we propose to develop a community of practice through
intentional mentoring. Intentionality in mentoring incorporates purposeful efforts to improve relationships by
utilizing best-practice mentoring behaviors, such as those supported through CIMER training. Community of
practice suggests that membership in the community is developed through not only knowledge transfer, but
skills, cultural norms, and social membership. The combination of intentional mentoring within the community
of practice framework incorporates both standard research support of mentees and psychosocial support. We
propose a three phase set of training activities in order to enhance the capacity for intentional mentoring and
development of a community of practice within qCMB, that will also spillover to other training programs, and
programs in general, at CSU. These phases focus on 1) qCMB faculty mentor training, 2) mentor training for
graduate student qCMB trainees, and 3) development of a community of practice to allow for supported
application of mentoring skills. These training activities will be capped with assessment and feedback of the
learned and applied mentoring skills.

Public health relevance
Narrative The aim of this proposal is to ensure that faculty within Colorado State University (CSU) are providing the best quality mentoring to our graduate student participants of the NIH funded qCMB program, other NIH funded Training programs, and other programs all through the university, and to also prepare our graduate students for mentoring roles as they progress through, and after they graduate, from this program. To do so we propose to develop a community of practice through intentional mentoring that includes three phases focusing on 1) qCMB faculty mentor training, 2) mentor training for graduate student qCMB trainees, and 3) development of a community of practice to allow for supported application of mentoring skills. These training activities will be capped with assessment and feedback of the learned and applied mentoring skills.